Multiple sclerosis as a cytodegenerative proteopathy

Project Summary/Abstract
MS is traditionally considered to be an autoimmune demyelinating disorder of the CNS. However there are a
number of inconsistencies with this “outside-in” hypothesis of MS pathogenesis which lead us to propose
instead that MS is primarily an “inside-out” disease, where a primary degeneration mainly targeting the myelin-
oligodendrocyte, secondarily entrains an auto-immune reaction in the predisposed host.
HYPOTHESIS: MS is a primary protein misfolding disorder targeting the myelinating unit, driven by
accumulation of transmissible protein aggregates. Specifically, this proteopathy is underpinned by a
pathological prion (in the generic sense) which promotes chronic toxicity of myelin and oligodendrocytes,
resulting in disruption of myelin integrity, leading to secondary autoimmunity, thus programming the broad
spectrum of inflammatory and progressive MS phenotypes.
Aim 1: Intracerebral transmission of MS-like pathology. This aim will conduct a detailed examination of our
ability to transmit an MS-like pathology from human brain homogenate (from deceased controls and
progressive MS subjects) to wild-type and humanized transgenic mice, via direct i.c. inoculation. This aim will
test the hypothesis that human MS brain contains toxic misfolded protein aggregates that can transmit
pathology and propagate in the recipient hosts. High- field MRI, (immuno)histology and behavior will be used
to monitor developing pathology. We expect to find pathology similar to “normal appearing white matter”
abnormalities in human MS brain (subtle myelinopathy, axonal damage, micro- and astrogliosis), and notably,
we do expect a significant lymphocytic response indicative of adaptive immunity. Negative controls (non-MS
human brain homogenate) will be performed to demonstrate MS specificity. Passaging (ie taking infected
transgenic mouse brain homogenate and re-inoculating into naïve mice) will show that the offending agent
continues to transmit. Prion protein is the etiological agent originally hypothesized, therefore experiments will
be tailored accordingly using PrP transgenics, recognizing that PrP and/or one of its interacting proteins could
also be playing a key role.
Aim 2: Intraperitoneal transmission of MS-like pathology. While direct i.c. inoculation is the most robust
method of transmitting prion-like misfolded proteins, it carries the risk of inducing non-specific pathology,
especially in strains that are more susceptible to various insults. This aim will attempt to transmit pathology via
a less invasive route using i.p. injections. Similar source material will be used. Advantages include potentially
earlier and more sensitive behavioural readouts (locomotor deficits, sensory abnormalities) if the expected
myelopathy is induced. Moreover, larger volumes of inocula and more frequent injections are possible with i.p.
compared to i.c. injection, potentially increasing the chances of transmission. Terminally, similar
(immuno)histology will be performed. We will also examine the spleen for evidence of misfolded protein
deposition as a clue to whether this organ participates in processing and amplification of transmissible seeds.
Aim 3: Biochemical analysis of human MS brain and passaged mouse CNS. A key observation made during
our preliminary biochemical studies showed a striking alteration in the interaction between prion protein and
myelin basic protein, one of the major myelin proteins. This aim will explore in greater detail this potentially
very important interaction that could be key for maintenance of myelin integrity. Immunoprecipitation, Westerns,
LC-MS and biochemical analysis will be performed to probe disruptions in this interaction. Focus will be on
citrullination of both proteins as this post- translational modification alters net charge, and therefore the
interaction efficiency, exerting a potentially important adverse influence on physiological protein-protein
interactions.

Public health relevance
Project Narrative Multiple sclerosis is a major cause of neurological disability in young adults in the western world. This project will fundamentally change our understanding of this disease by refocusing attention from the conventional autoimmune view, to one based on toxic protein misfolding promoting degeneration of axons, neurons and myelin. These insights will open completely new directions for therapeutic design that will complement current anti-inflammatory therapies, and more importantly, guide development of drugs for progressive MS where most irreversible disability occurs, and for which we currently have limited therapeutic options.